International Gap Junction Conference 2024

SUMMARY
The International Gap Junction Conference (IGJC) is a biannual international meeting that has been alternating
between Europe and America since 1987. This meeting is the only one of its kind that gathers scientists and
clinicians from all over the world to present and discuss research on connexins, pannexins, innexins, and gap
junction proteins in general. The most well-known connexin-mediated function is perhaps in formation of gap
junctions within cardiac muscle which provide direct intercellular electrical coupling necessary for each
heartbeat to occur. Alterations in connexin regulation and function are understood to cause arrhythmias of
sudden cardiac death, and a significant portion of IGJC2024 will be dedicated to normal and pathological
mechanisms of connexin regulation encompassing transcription, translation, post-translational modification,
channel biophysics/structure, and stability/degradation. In addition to intercellular communication, connexin
hemichannels occur on the cell surface, and increasing non-junctional cytosolic functions of connexins are
being uncovered. Pannexins share a protomeric structural similarity with connexins but are not considered to
form intercellular channels, but rather function intracellularly or as cell-surface channels controlling release of
ATP and other metabolites for purinergic signaling. Just as with connexins, but through distinct mechanisms,
pannexin function is closely related to heart and vascular biology, with significant roles in heart disease
progression and blood pressure maintenance, for example. Pannexins have evolved from innexins, which form
gap junctions in invertebrates. There has been a recent resurgence in innexin research using model organisms
which is providing further insight as to evolution and mechanisms of pannexin/connexin structure and function.
By combining these three dynamic fields of research, the IGJC provides a uniquely diverse and rich intellectual
space with a demonstrated history of fostering collaboration to move the field forward and providing support
and exposure for early career investigators to share their science. It is our overall Aim to ensure that IGJC2024
continues the success of this highly anticipated and long-running forum by facilitating the dissemination of new
discoveries, fostering collaboration, and attracting trainees from diverse backgrounds supporting early-career
investigators in the fields of connexin, pannexin, and innexin biology.

Public health relevance
NARRATIVE The International Gap Junction Conference (IGJC) is a biannual international meeting that has been ongoing since 1987. This meeting is the only one of its kind that gathers scientists and clinicians from all over the world to present and discuss research on critical proteins that allow human cells to communicate with each other and the spaces around them. This is relevant to public health because there proteins are altered in almost all human disease states and research shared and collaborations forged at the meeting will contribute to development of therapies targeting heart disease, neurological disorders, and cancer; to name a few.